9.4T MRI gradients

The requested instrument, the gradient system for a 9.4T imager, represents a substantial
advancement in the methodology of translational research. This device will replace the current,
degrading system currently in use in the imager. The current gradient is suffering from over 15
years of wear, which has led to the deterioration of the insulation materials that separate the
gradient and shim coils. Consequently, we have observed that the electrical couplings between
the gradient and shim coils caused a significant distortion in the images produced. This
indication, among others outlined in the proposal below suggest that the current gradient system
is at increasing risk of sudden failure without any warning. The gradient system’s integrated
design will be a complete and lasting fix for these issues. Furthermore, it will permit researchers
to continue and accomplish important NIH-funded research, through the use of various
magnetic resonance (MR) modalities which promote robust empirical findings. The proposed
projects that will utilize the system will aim to identify the developmental and cellular
mechanisms of resting state functional MR imaging (fMRI) in healthy state and after perinatal
brain injury, the MR signature of developmental effects after neonatal anesthesia, understand
the physiology of visceral pain, etc. At present, NorthShore University HealthSystem does not
currently possess an alternative instrument capable of conducting this type of research even
though the PI and their team already has obtained the necessary experience and expertise to
safely and effectively implement and operate the gradient system with immediate effect. The
gradient system along with the enthusiastic institutional support will unquestionably facilitate the
progression of research in line with the mission of NIGMS as well as NorthShore University
HealthSystem by enabling immediate and impact-driven research to preserve and improve
human life.

Public health relevance
Magnetic resonance imaging (MRI) is currently experiencing increased interest and growth of its applications in both children and adults. The gradient system will enable us to apply a wide variety of MR modalities to enhance the understanding of the cellular mechanisms behind functional MRI, observe the physiological and developmental alterations that result from perinatal and neonatal injury and drive advances in many other research and translational topics.